Testing a Biosocial Model of Borderline Personality Features in Youth

Project Summary
Borderline personality disorder (BPD) is a complex and debilitating disorder associated with pronounced
social dysfunction, frequent suicidal behavior, and high rates of treatment utilization. Although traditionally
diagnosed in adulthood, prominent models of BPD trace the developmental origins of BPD back to childhood.
There is mounting evidence that features of BPD may emerge in childhood, predicting poor functional outcomes
beyond more commonly diagnosed childhood mental health problems (e.g., depression, anxiety, attention-
deficit/hyperactivity disorder, and conduct problems) as well as high risk for the development of BPD into
adolescence and adulthood. Yet, very little work has examined neural mechanisms underlying BPD features in
youth, hindering efforts to identify and target those youth at highest risk for BPD. Youth at risk for BPD
demonstrate deficits in the NIMH RDoC domains of Cognitive Control and Attachment and Affiliation. At the self-
report and behavioral level, youth with BPD features have been shown to display deficits in response inhibition,
one aspect of Cognitive Control, which involves the ability to suppress a prepotent urge to act. Similarly, there is
also some evidence, at the behavioral and self-report level, that deficits in social processing are central to the
Attachment and Affiliation difficulties of individuals with BPD features. Sensitivity to social rejection is a primary
clinical focus in intervention for BPD, although co-occurring mood and anxiety difficulties also contribute to
rejection sensitivity. Emerging work suggests unique alterations in social acceptance processing among
individuals with BPD, particularly difficulties modulating responses to acceptance cues. Deficits in response
inhibition and social acceptance processing have been reliably elicited in youth at the neurophysiological level
using event-related potentials (ERPs) derived from the electroencephalogram (EEG), although they have not
specifically been used to examine mechanisms of BPD features. Attention to neurophysiological mechanisms
underlying risk for BPD may offer critical insight into reducing the societal and personal burden of BPD. For this
work, a sample of 100 girls (ages 10-13) will be recruited. The majority of girls (n=70) will be recruited from two
clinically diverse outpatient psychiatry clinics, while the remaining (n=30) girls will be healthy controls without a
history of psychopathology. Neurophysiological assessments of response inhibition and social acceptance
processing will be administered, and response inhibition and social acceptance processing measured at the
neurophysiological level will be tested as mechanisms underlying growth in BPD features 6 and 12 months after
the initial assessment. Lastly, harsh parenting and peer victimization will be explored as moderators of
associations between response inhibition, social acceptance processing, and growth in BPD features. Results
from this work will validate the utility of assessing BPD features in youth and provide evidence on mechanisms
that can be targeted in early intervention for youth at high risk for the development of BPD.

Public health relevance
PROJECT NARRATIVE Very little empirical work has explored early neurophysiological mechanisms of risk for borderline personality disorder (BPD) in youth, although prominent models trace the developmental origins of the disorder back to childhood. For this prospective study, a clinically diverse psychiatric outpatient sample of 70 early adolescent girls and 30 healthy comparison girls without a history of psychopathology (ages 10-13) will be recruited to test neurophysiological alterations in response inhibition and social acceptance processing as mechanisms underlying risk for BPD over the course of a year. The impact of negative environmental influences, including harsh parenting and peer victimization, will also be explored in emerging risk for BPD in order to identify targets for early identification and intervention.